JHU Statistical and Safety Resource Center (SSRC)

ABSTRACT
The JHU SSRC is an established, functioning team of multisite trial PIs, experienced
lead managers, administrators, and scientists. BIOS, a JHU Clinical Trials Coordinating
Center, will operationally convene this group and provide staff to execute the required
Statistical and Safety Resource Center program and its specific assigned tasks in the
areas of statistics, safety, and DSMB management. Our joint expertise, developing and
managing trials in these specified areas extends well beyond the last five years of work
on the ongoing HEAL Pain ERN studies with our group having served as clinical
coordinating centers and data coordinating centers for dozens of large multi-centered
clinical trials at various NIH ICs. Together with our partners at Duke, Utah, and
Vanderbilt, we will support the awardee team for the new sickle cell trial in the same
collaborative and comprehensive manner that has been demonstrated for the ongoing
five trials currently awarded as part of the HEAL Pain ERN initiative.

Public health relevance
NARRATIVE The NIH has created the Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. Trials will be conducted through the NIH HEAL Pain Management Effectiveness Research Network (HEAL Pain ERN), which will use the infrastructure of the NCATS Trial Innovation Network to provide scientific guidance and coordination of the HEAL Pain ERN Trials. The four resource centers will provide integrated functions for the clinical coordinating resource center, data coordinating resource center statistics and safety resource center, and recruitment resource center with Johns Hopkins serving as the Statistics and Safety Resource Center.